The genetics of tumor suppression by p53 - Diversity Supplement

Project Summary
This is a request for a supplement to R01 CA279585 to train Ms. Andrea Valdespino, a highly talented
graduate student from the University of Pennsylvania to train with Dr. Maureen Murphy at the Wistar
Institute. The overarching goal of the parent R01 is to identify and test a gene expression signature for
genetic variants of TP53; this goal followed from our recent publication that identified a 143-gene
expression signature that accurately predicts whether heterozygous B cells contain a p53 hypomorph (a
lesser functioning genetic variant) versus wild type (WT) p53 or a benign (fully functional) variant. This
goal is critical to the 4.5 million people in the United States that are heterozygous for a lesser-functioning
“hypomorphic” p53 allele, but who are currently categorized as a “variant of uncertain significance (VUS)”.
As a VUS carrier, these individuals are uninformed as to cancer risk and they do not qualify for MRI
screening for cancer. Ms. Valdespino has obtained very new data indicating that the interferon signaling
pathway (IFN) is significantly upregulated in cells from p53 hypomorphs compared to WT sibling controls.
The two aims of the proposed research will: 1) identify the mechanism underlying increased IFN signaling
in hypomorph B cells, with focus on the dsRNA/TLR3 pathway and the mitochondrial/dsDNA pathway, and
2) test the other thirty cell lines in the laboratory from hypomorph carriers, compared to WT controls, for
activation of IFN signaling. The hope is to determine whether including an activated IFN signaling pathway
in our analysis improves the identification of individuals with an impaired p53 pathway. Such an outcome
would allow for improved assessment of cancer risk in carriers with genetic variants of p53.

Public health relevance
Project Narrative The proposed research seeks to test the hypothesis that increased interferon (IFN) signaling is a common phenomenon in non-transformed B cells from carriers of p53 hypomorphs, compared to WT p53 or benign variants. The proposed research seeks to determine the mechanism underlying increased IFN signaling, and test the hypothesis that increased IFN signaling is a biomarker for hypomorphic p53.